Role of ACER2 in cancer chemoresistance and metastasis

Neoadjuvant chemotherapy (NAC) has become an increasingly popular treatment approach for breast cancer
(BC) patients. It enables locally advanced and inflammatory BC patients to be eligible for breast conservative
surgery. However, emerging evidence suggests that preoperative NAC may paradoxically increase the risk of
BC cancer chemoresistance and progression, thus limiting its therapeutic efficacy. The specific goals of this
application are to define a novel role for alkaline ceramidase 2 (ACER2) in mediating NAC-induced
chemoresistance and metastasis of BC and to develop this concept into novel therapeutic approaches to
improving BC therapy. ACER2 is a member in the alkaline ceramidase family that we identified initially from the
yeast Saccharomyces cerevisiae and then from mammals. ACER2 catalyzes the hydrolysis of ceramide to
generate sphingosine (SPH), which is immediately converted to sphingosine-1-phosphate (S1P), a bioactive lipid
that has been implicated in tumor angiogenesis and lymphangiogenesis, protumoral immune responses, and
cancer stem cell survival. Our preliminary studies demonstrate that doxorubicin (DOX), a chemotherapeutic
agent commonly used in BC patients, induces a marked increase in the levels of S1P in in the tumor, primary
site of the tumor (mammary fat pads), and major metastatic tissues of BC (brain, bone marrow, liver, and lungs)
in a syngeneic mouse model of BC. We further show that knocking out the mouse alkaline ceramidase 2 gene
(Acer2) from host cells markedly inhibits DOX-induced increase in the levels of S1P in the tumor and the
aforementioned tissues, robustly augments DOX-induced tumor growth inhibition, and inhibits DOX-induced
pulmonary metastasis of BC. These compelling results support our hypothesis that NAC-induced upregulation
of the ACER2/S1P pathway mediates BC chemoresistance and metastasis. As a further corollary, we
hypothesize that blocking the ACER2/S1P pathway with an ACER2 inhibitor (ACER2i) will improve the
therapeutic efficacy of chemotherapeutic agents against BC by mitigating chemotherapy-induced
chemoresistance and metastasis of BC. To test these hypotheses, we will 1) establish that ACER2 mediates
NAC-induced chemoresistance and metastasis of BC (Aim 1); 2) Define the molecular and cellular mechanisms
by ACER2 mediates NAC-induced chemoresistance and metastasis (Aim 2); and 3) Establish that targeting
ACER2 with its small molecule inhibitor (ACER2i) would mitigate NAC-induced chemoresistance and metastasis
of BC and thereby improves NAC of BC (Aim 3). Successful completion of these aims will 1) validate the
pathological role of the ACER2/S1P pathway in cancer chemoresistance, metastasis, and recurrence; and 2)
provide a proof of concept that targeting the ACER2 pathway would improve BC chemotherapy. Given the poor
clinical outcome of patients with most cancers, these studies may have widespread impact on the clinical
management of these patients.

Public health relevance
Breast cancer (BC) is a leading cause of cancer deaths in women in the U.S. and worldwide. BC remains refractory to many treatment options; hence, new therapeutic modalities are urgently needed. The specific goals of this application are 1) to investigate how alkaline ceramidase 2 (ACER2), a newly identified target of DNA- damaging chemotherapeutic agents in mediating cancer chemoresistance, metastasis, and recurrence; and 2) to develop novel approaches to overcoming BC chemoresistance and chemotherapy-induced metastatic recurrence by targeting ACER2.